RepurPosed AntiretrOviraL ThErapieS to EliminAte Cervical Cancer (POLESA Trial)

Project Summary/Abstract
As the death toll from cervical cancer continues to rise, particularly in low-resource settings, we
are in search of more effective approaches to cervical cancer prevention. In the absence of
cytology- and HPV-based cervical cancer screening, experts have endorsed screening of the
cervix by visual inspection after application of acetic acid (VIA) to highlight precancerous or
cancerous abnormalities. If the recognized acetowhite pattern is perceived to be abnormal, the
cervical epithelium is either ablated by freezing (cryotherapy) or heating (thermal ablation) in a
“see and treat” approach or excised with a large loop excision of the transformation zone (LLETZ).
This approach to cervical cancer screening and treatment has been widely adopted in low- and
middle-income countries (LMICs), notably in sub-Saharan Africa (SSA), which has some of the
world’s highest rates of cervical cancer. Our team conducted one of the largest randomized
controlled trials ever conducted in SSA comparing these treatment approaches. Our preliminary
results suggest that these treatments are almost 50% less effective for women living with HIV
(WLWH). As evidenced by these findings, the elimination of cervical cancer as a significant public
health disease requires the adoption and implementation of strategies that are easily accessible,
affordable, acceptable and are equally efficacious in WLWH. One potential therapeutic agent that
warrants further investigation is a vaginal capsule containing the protease inhibitors (PIs)
Lopinavir and Ritonavir (LPV/r), which have known anti-cancer and HPV activity. The overall goal
of this trial is to find new, non-invasive, easily scalable solutions that address the profound gap in
secondary cervical cancer prevention, particularly among WLWH. The central aim of this study is
to assess the safety and acceptability of the LPV/r vaginal capsule given alone or in combination
with thermal ablation to treat VIA positive women who are eligible for ablative therapy. We will
enroll 180 women who present for cervical cancer screening in a Cervical Cancer Prevention
Program clinic in Zambia. Participants (n=180) will be stratified based on HIV status and
randomized to receive 1) LPV/r or placebo for 3 weeks followed by thermal ablation at 4 weeks
or 2) LPV/r or placebo alone for 3 weeks with repeat VIA at 6 months and thermal ablation for
those with persistent VIA positive cervical lesions. Twenty of the 180 VIA positive women will be
randomized to a comparator cohort of usual care with immediate TA if eligible. The expected
outcome of this work is the generation of evidence that this novel LPV/r treatment is safe and
acceptable for use as treatment or adjunct in women who screen VIA positive. Results from this
study will lay the groundwork for a large-scale study of LPV/r in a SSA cohort.

Public health relevance
Project Narrative The elimination of cervical cancer as a public health disease requires the adoption and implementation of strategies that are easily accessible, affordable, acceptable and are equally efficacious in women living with HIV. Hence, we will study the safety and acceptability of a novel formulation of a combination protease inhibitor (Lopinavir/Ritonavir) developed as a self- administered vaginal capsule for use as treatment or an adjunct to treatment for women who screen VIA positive, a surrogate for cervical precancer. Additionally, we seek to establish pilot efficacy data in support of implementing a large-scale clinical trial of this innovative approach to secondary cervical cancer prevention.